Spherical Nucleic Acid nano-architectures as first-in-class cGAS agonists for the immunotherapeutic treatment of Glioblastoma.

Vaccines, drugs, and modified human cells that activate the immune system against tumor can improve the
outcomes and prolong the lives of patients diagnosed with some type of cancers, but have failed to provide
survival benefits for patients with glioblastoma (GBM). Activation of the Stimulator of Interferon Genes (STING)
pathway represents one of the main innate immune sensing pathway to enable natural killer (NK) and T cell
priming against tumor. Intratumoral administration of STING agonists, in particular cyclic dinucleotides (CDNs),
was shown to have significant anti-tumor effects in multiple cancer models, including orthotopic GBM models,
and is currently being tested in a phase 1 clinical trial in advanced cancer patients (NCT0267754339). Limited
bioavailability and stability, however, are limiting factors for clinical CDN development.
We have shown that the formulation of oligonucleotides into SNA structures, i.e., the presentation of
oligonucleotides at high density on the surface of nanoparticles, leads to biochemical and biological properties
that are radically different from those of linear (“free”) oligonucleotides. These include the cellular uptake of SNAs
by a wide variety of cells, the gene regulatory activity of SNAs functionalized with siRNA or antisense DNA
oligonucleotides, and the TLR-agonistic activity of SNAs conjugated with immunostimulatory oligonucleotides.
Importantly, clinical trials with first generation siRNA-based SNAs (NCT03020017; GBM), and toll-like receptor
9 (TLR9)-agonsitic SNAs (NCT03086278; solid cancers) have recently been completed.
Our proposed research is to develop a first-in-class immunotherapy by targeting cGAS – the sensor of cytosolic
dsDNA upstream of STING – with SNAs presenting interferon-stimulating DNA (ISD) oligonucleotides at high
surface density, and to evaluate the potential of SNAcGAS for use in clinical neuro-oncology. This approach is
distinct from other current approaches that target the STING pathway with CDNs and small molecules. By
targeting cGAS, the strategy of using SNAsISD exploits the ability of cGAS to raise STING responses by delivering
dsDNA and inducing the catalytic production of endogenous CDNs. Our use of SNAs addresses the challenges
of delivery of therapeutic nucleic acids through the enhanced uptake of nucleic acids formulated as SNAs, and
furthermore, exploits the polyvalent presentation of oligonucleotides at high density on a nanoparticle template.
Here, the binding of closely-spaced, neighboring dsDNA molecules on the surfaces of SNAs should enhance
the formation of 2:2 dimers of cGAS:DNA and thus lead to potent cGAS activation. In three Specific Aims, we
will optimize the SNA platform for maximum cGAS-STING pathway activation in vitro and in vivo (Aim 1), assess
anti-tumor effect of our lead SNAcGAS architectures together with additional high-activity SNA constructs in vivo
(Aim 2), and evaluate treatment regimens combining SNAcGAS with prioritized immunotherapies, including check
point blockade and pharmacological strategies to inhibit adenosine signaling (Aim 3).

Public health relevance
In this proposal, we will develop Spherical Nucleic Acid (SNA) nanoconjugates as a novel class of cGAS- STING pathway agonists. We will evaluate their anti-tumor effect as monotherapy and when combined with existing immunomodulatory approaches to credential SNAs as a novel immunotherapeutic modality for the treatment of malignant brain tumors.